The kidney in advanced heart failure and durable mechanical circulatory support: phenotypes, prediction, and pathophysiology

PROJECT SUMMARY/ABSTRACT: This proposal outlines a 5-year mentored training program to develop
Carl Walther, MD, MS, Assistant Professor of Medicine-Nephrology at Baylor College of Medicine, into an
independent clinical investigator. Dr. Walther is a board-certified nephrologist with a Master of Science in
Clinical Research. His research focuses on the nexus of kidney disease and heart disease, in particular the
high burden of kidney disease in the rapidly growing field of durable mechanical circulatory support (primarily
left ventricular assist devices [LVADs]) for advanced heart failure (HF). This proposal contains an integrated
training and research plan to build Dr. Walther’s strong foundation of knowledge and experience into expertise
in innovative research methods and practice to improve kidney disease in LVAD recipients and others with
advanced heart failure. The career goals are: 1) train in the advanced/modern analytic and statistical
techniques necessary to obtain valid, useful, individualized information from dense, multidimensional data; 2)
develop expertise in physiology and prospective research techniques, including translational biomarker
science, necessary for individualized characterization of kidney and cardiovascular health; 3) experience
leading a prospective, multispecialty, collaborative study in a multimorbid population. The integrated,
collaborative training and research plan includes formal coursework, mentored activities, conferences and
targeted short courses, and will be performed in the outstanding environment of Baylor and the Texas Medical
Center. He will be guided by a team of senior mentors and consultants with broad expertise: advanced analytic
methods (Wolfgang Winkelmayer, MD, MPH, DSc and Jesse Schold, PhD), translational biomarker science
(Steven Coca, DO, MS), prospective kidney research (Sankar Navaneethan MD, MPH, MS), prospective
mechanical circulatory support research (Kenneth Liao, MD, PhD), and functional kidney imaging (Emily
Chang, MD). The specific aims unify to precisely understand and predict adverse kidney outcomes with
durable mechanical circulatory support. Aim 1 will identify novel global phenotypes in advanced heart failure at
high risk for important adverse kidney outcomes, leveraging an existing national database. Aim 2 will
prospectively assess how kidney parenchymal health prior to LVAD implantation (measured non-invasively,
using a panel of kidney biomarkers) is related to important kidney outcomes. Aim 3 will study how kidney
parenchymal health changes during long-term mechanical circulatory support, and the relationship of
longitudinal kidney parenchymal health with neurohormonal activation and inflammation. This research is
innovative in its precise approach to understanding and predicting the effects of durable mechanical circulatory
support on global kidney health, an essential step towards reducing the growing burden of cardiorenal disease.

Public health relevance
NARRATIVE: Left ventricular assist devices (LVADs) are increasingly used in the US to support heart function in the growing population with advanced heart failure, and they can improve length and quality of life. However, worsening or persistent kidney dysfunction after LVAD placement is common and harmful. This project seeks to understand and predict how LVADs affect kidney health, to help patients who receive LVADs achieve longer, healthier lives.